Single Cell Analysis of Epigenetic Mechanisms that Regulate HIV-1 CNS Latency and Neuropathogenesis

Current antiretroviral therapies (ART) are successful in suppressing HIV-1 replication in most individuals.
However, cessation of ART results in emergence of HIV-1 from a latent viral reservoir, thereby requiring a
lifetime ART regime. The best-described HIV-1 reservoir is that of CD4+ T lymphocytes in circulating blood
and lymphoid tissues that contain a transcriptionally silent but replication-competent virus. The brain is also an
important viral reservoir site, but it is poorly characterized due to the challenges in obtaining specimens for
analyses. Despite its effectiveness, multiple toxicities are associated with ART, especially the high prevalence
of HIV-associated neurocognitive deficits. The research described in this application will use human autopsy
specimens to investigate two key issues regarding HIV-1 infection of the brain: 1) epigenetic mechanisms that
regulate active and latent HIV-1 infection in the brain; 2) mechanisms underlying neuropathogenesis and
neurocognitive deficits in HIV-1-infected individuals on suppressive ART. Brain specimens from prefrontal
cortex and hippocampus from HIV-1 infected individuals treated with ART death will be obtained from the
National NeuroAIDS Consortium. Matched HIV-1-negative control specimens will be obtained from the
UTHealth Brain Collection. Single cell RNA sequencing technology will be utilized to identify long noncoding
RNAs (lncRNAs), mRNAs, and microRNAs (miRNAs) that are dysregulated in HIV-1-infected individuals.
Validation experiments will be performed in HIV-1-infected microglia cells to identify dysregulated lncRNAs and
miRNAs that contribute to HIV-1 replication, latency, and neuropathogenesis. Completion of the proposed
work is likely to identify therapeutic approaches to treat HIV-1 infection of the brain.

Public health relevance
The research will utilize single cell RNA sequencing technology to examine brain autopsy specimens from individuals who were HIV-1-infected and treated with suppressive antiviral therapy prior to death. The research will focus on mechanisms that regulate HIV-1 replication, latency, and neuropathogenesis in the brain. The project will inform therapeutic strategies to tackle the HIV-1 infection of the brain.